Investigating a Wnt-telomere feedback loop in the colorectal adenoma-carcinoma sequence

ABSTRACT:
Colorectal adenocarcinoma (CRC) is a leading cause of cancer deaths globally. CRC tumorigenesis
proceeds through a model of stepwise transformation of the colonic epithelium from benign adenoma to invasive
carcinoma. This genetic process generally initiates from loss-of-function mutations in APC, which hyperactivate
the Wnt signaling pathway, and requires eventual mutations in p53 for tumor progression and invasion. A majority
of CRC cases is also characterized by chromosomal instability (CIN), which arises early and increases through
tumor progression and which enables mutations that drive carcinogenesis. Despite enablement of transformation
by CIN, the mechanisms by which CIN arises are not completely understood. A strong candidate contributor to
CIN in early CRC is telomere dysfunction, which occurs when chromosome ends become shortened and
uncapped and activate a DNA damage response (DDR) that leads to chromosome end-fusions. Telomere
erosion and fusions have been observed in adenoma and carcinoma biopsies and have been shown to correlate
with CIN, consistent with the possibility that telomeres may function as a driver of carcinogenesis. Given these
observations, a deeper understanding of the mechanisms that regulate telomere capping and the consequences
of telomere uncapping during CRC progression is needed. Our laboratory previously uncovered a novel feedback
loop between telomere capping and Wnt signaling that contributes to homeostatic intestinal maintenance in mice
and humans. Through this loop, loss of telomere capping leads to a broad suppression of Wnt pathway activity
in intestinal crypt epithelia and underlying stroma. We determined that in mice this regulation involves p53-
mediated expression miR-34a, a p53-activated microRNA which targets Wnt pathway components. Moreover,
activation of the Wnt pathway reinforces telomere capping through upregulation of the shelterin protein TRF2.
Thus, telomere capping and Wnt signaling in the gut are mutually supportive, and dysregulation of this feedback
loop in CRC may be permissive for cells harboring dysfunctional telomeres. The study proposed herein aims to
understand how oncogenic CRC mutations that might compromise Wnt-telomere feedback impact telomere
status during CRC progression, as well as the extent to which perturbed telomere capping promotes tumor
growth. My central hypothesis is that the regulatory loop between Wnt signaling and telomere capping is
disrupted in CRC such that dysfunctional telomeres enhance, rather than inhibit, tumorigenesis. In Aim 1, I will
use a human colonic organoid model to determine how APC and p53 mutations disrupt Wnt-telomere feedback.
In Aim 2, I will characterize the relationship between these mutations and Wnt signaling/TRF2 expression in
human CRC samples and determine whether induced telomere dysfunction in the setting of APC and p53 loss
enhances organoid growth in murine xenografts. Taken together, these studies will provide unprecedented
insight into telomere dysfunction as a driver of early CRC tumorigenesis and reveal new information about the
mutational landscape of developing colon tumors.

Public health relevance
PROJECT NARRATIVE: The extent to which short, uncapped telomeres contribute to chromosome instability in premalignant colon lesions to promote colon tumorigenesis in humans is poorly understood. Additionally, it is unclear whether loss of function of the two most commonly mutated tumor suppressors in colon cancer, APC and p53, are permissive for tumor growth in the presence of eroded telomeres. The experiments outlined in this proposal will provide robust tests of whether telomere dysfunction is pro-tumorigenic in the context of APC- and p53-mutant colon cancer, and will illuminate underlying mechanisms.